ACTG 384, PROTEASE &NON NUCLEOSIDE REVERSE TRANSCRIPTASE INHIBITOR FOR HIV

This multicenter trial will evaluate three treatment regimens to block virus replication and prevent immunologic damanger in HIV infected subjects.